Circuit specializations of developing visual networks

The visual pathways of the human fetal brain are highly active before birth. During this pre-visual period
spontaneous activity in the retina provides the primary input to visual brain and data from neonatal rodents
implicate this early activity in normal development and organization of visual pathways. While we understand
much about the specialized circuits that produce activity in the developing retina, and the consequences of
disruption of that activity for eye and brain outcomes, we know little of the brain activity that supports the
earliest stages of sensory development. Early retinal activity is not passively transmitted in the developing
brain. Rather, it is actively amplified and transformed by mechanisms unique to this developmental stage.
This proposal will use a rodent model of human fetal brain development to follow the propagation and
transformation of early retinal activity at each stage of the primary visual pathway in thalamus and visual
cortex, to understand the mechanisms of its transformation, the role of individual thalamic regions, and the
ultimate impact of this circuit on functional visual maps and responsiveness. This knowledge is important
because disruption of early retinal, thalamic, or cortical activity associated with preterm birth or hypoxic birth
complications can cause lasting visual impairment. Any treatment or early diagnosis (such as using EEG)
requires knowledge of the normal developmental circuitry, activity and function of thalamus and cortex, which
this project will provide.

Public health relevance
Before you can see the retina produces neural activity that guides development of the brain’s visual system. This project will explore how the cortex and the thalamus work together to actively transform this input to a form uniquely suited for early visual maturation, using a rodent model of fetal brain development. Our long- term objective is to understand the special role that fetal rhythms play in the maturation of vision, to be able to identify and treat consequences of preterm birth and perinatal brain injury such as cerebral visual impairment.